Chemical and Molecular Tools for Modulating GPCR Function

PROJECT SUMMARY/ABSTRACT
Evidence from human imaging, postmortem analysis, and animal models suggests that atrophy of neurons in
the prefrontal cortex (PFC) plays a key role in the pathophysiology of both neuropsychiatric and
neurodegenerative diseases. Structural changes—including retraction of dendritic arbors, loss of dendritic
spines, and reductions in synapse density—lead to functional deficits that manifest as impaired cognition,
decreased motivation, anhedonia, high anxiety, and increased impulsivity. Thus, therapeutic strategies aiming
to restore PFC structure/function have broad therapeutic potential. Psychoplastogens—small molecules that
promote structural and functional neuroplasticity in the PFC—produce both rapid and long-lasting therapeutic
effects after a single administration. However, many psychoplastogens, including ketamine and serotonergic
psychedelics, induce hallucinations, which greatly limit their therapeutic potential and clinical scalability.
Fortunately, increasing evidence suggests that the hallucinogenic effects of ketamine and psychedelics may
not be necessary for their therapeutic properties, and our group recently introduced the first non-hallucinogenic
psychoplastogens. The advent of non-hallucinogenic psychoplastogens represents an exciting new direction
for the treatment of many brain disorders, but there is an urgent need to further optimize their efficacy and
safety profiles. Our primary goals are to, 1) establish robust synthetic strategies to psychoplastogenic natural
products and chemical scaffolds that are amenable to medicinal chemistry, 2) develop high-throughput cellular
assays for assessing psychoplastogen efficacy and safety, and 3) advance new in vivo assays uniquely suited
to evaluate the long-lasting effects of psychoplastogens. Taken together, these efforts will enable structure-
activity relationship (SAR) studies of key psychoplastogenic scaffolds, filling the gap in our knowledge about
which structural motifs are critical for both psychoplastogenic and hallucinogenic effects. Ultimately, the work
described here will enable the rational design of safer, non-hallucinogenic alternatives to psychedelics for
treating a wide variety of neuropsychiatric and neurodegenerative diseases.

Public health relevance
PROJECT NARRATIVE Compounds capable of promoting neuroplasticity, such as ketamine and serotonergic psychedelics, have enormous potential for treating neuropsychiatric and neurodegenerative diseases characterized by cortical atrophy, but their hallucinogenic effects limit their clinical scalability. Recently, our group discovered that it is possible to engineer non-hallucinogenic analogs of psychedelics capable of promoting neuroplasticity after a single administration and producing sustained therapeutic effects across disease indications. The research described here seeks to establish new synthetic strategies for accessing plasticity-promoting compounds as well as methods for evaluating their efficacy, safety, and mechanisms of action—information that will ultimately lead to the development of new treatments for diseases such as depression, posttraumatic stress disorder, substance use disorder, Alzheimer’s disease, and Parkinson’s disease, among others.